IGF::OT::IGF -- logistical support services for the event titled, "Workshop: Intersection of Aging Biology and Pathobiology of Lung Diseases"

Logistical support services for the event titled, Workshop: Intersection of Aging Biology and Pathobiology of Lung Diseases